Anticancer ELNP nanovaccines for curative treatmentof pancreatic cancer

The ultimate goal of this project is to develop innovative anticancer nanovaccines utilizing
multifunctional ionizable lipid nanoparticles for the curative treatment of pancreatic ductal
adenocarcinoma (PDAC). PDAC is recognized for its aggressive nature and notably poor long-
term survival rates, presenting a pressing clinical need for effective curative therapies. While
cancer immunotherapy has demonstrated the potential for disease-free outcomes, the efficacy of
current clinical immunotherapies for PDAC is limited by the immunosuppressive tumor
microenvironment. Our central hypothesis is that innovative nanosized therapeutic cancer
vaccines, specifically targeting multiple mutant oncogenes in pancreatic ductal adenocarcinoma
(PDAC), could potentially overcome tumor heterogeneity, thereby achieving a high rate of
disease-free survival. Additionally, we believe that the synergistic combination of these
nanovaccines with inhibitors targeting a potent immune checkpoint protein could markedly
amplify antitumor immune responses and enhance overall therapeutic efficacy. To non-
invasively assess the therapeutic impact of these nanovaccines, we will utilize cutting-edge
magnetic resonance molecular imaging (MRMI) technology. This approach will not only facilitate
the real-time evaluation of the nanovaccines' effectiveness but also guide the fine-tuning of both
the nanovaccine formulation and the immunotherapy protocol. Towards this, we will 1) to design
and develop multifunctional ionizable ELNP based peptide vaccine for effective immunotherapy
of PDAC; 2) to determine therapeutic efficacy of the ELNP vaccines to treat PDAC in mouse
models under MRMI guidance; 3) to explore the combination therapy of nanovaccine and VISTA
blockade to improve the disease-free therapeutic outcomes. Multidisciplinary approaches will be
applied to this project by a research team with complementary expertise in cancer biology,
immunology, oncology, pathology, drug delivery, molecular imaging, and biomedical engineering
from Case Western Reserve University and Cleveland Clinic. The successful completion of this
project holds the promise of developing groundbreaking therapeutics tailored to meet the urgent
clinical needs in the treatment of PDAC patients.

Public health relevance
Project Narrative The project aims to develop an innovative anticancer nanovaccine for the treatment of pancreatic cancer, targeting the key challenges of limiting factors and tumor heterogeneity to enhance the effectiveness of immunotherapy. The successful completion of this project is expected to introduce a potent therapeutic option for the curative treatment of lethal pancreatic cancer, significantly improving the disease-free survival rate among patients.